Morphogen control of organ growth in Drosophila

PROJECT SUMMARY
The main goal of this project is to determine how morphogens control organ growth. During development, each
body part grows to full size and differentiates complex cell patterns under the control of morphogens, secreted
signaling molecules that spread through developing tissues and organize gene expression, pattern and growth.
The major superfamilies of morphogens are conserved in all multicellular animals, from sponges to man.
Understanding how they work has enormous implications for human health, as genetic and environmental
perturbations of their activities and signal transduction pathways cause diverse developmental and physiological
disorders as well as a wide range of cancers. Research on morphogens is thus critical for developing diagnostic
and therapeutic tools to treat human disease, a central mission of the NIH. Our past studies, using Drosophila,
established that members of two superfamilies of secreted proteins, Bone Morphogenetic Proteins (BMPs) and
Wingless/Ints (Wnts) function as bona fide morphogens. Initially we focused on the logic and molecular
mechanisms by which these molecules control gene expression and patterning. Here we turn to the fundamental
and enduring mystery of how they control growth. In the proposed research, we will fill three key gaps in
understanding. First, we will consolidate and extend a new “feed-forward” model for growth based on our recent
discoveries unifying the roles of Decapentaplegic (Dpp, a BMP) and Wingless (Wg) in the developing Drosophila
wing, a classic paradigm for morphogen action. In this model, Wg and Dpp act together to induce and sustain
expression of the selector gene, vestigial (vg), which encodes a transcription factor that “selects” the wing state
and programs wing cells to grow in response to Wg and Dpp. We identified a single enhancer element in
the vg gene that integrates Dpp and Wg input, as well as a “recruitment” signal, the protocadherin Fat. We will
now combine genetic, transgenic and molecular approaches to determine how this integration occurs and to
identify downstream effectors that govern wing growth in response to Dpp and Wg. We will also test a key axiom
of the model—that Dpp and Wg are required continuously, at long-range, to sustain growth—and determine how
these molecules move through tissue. Second, we will apply the approaches and principles that have emerged
from our analysis of the fly wing to elucidate how Dpp and Wg control the growth of other organs. We will focus
on the fly leg in which Dpp and Wg as well as their downstream selector genes and signaling molecules are
deployed in a manner that is highly conserved throughout the animal kingdom, but distinct from the wing. Our
analysis will build on our preliminary evidence that leg growth is governed by the ranges of Dpp and Wg—as in
the wing—but by different regulatory circuits and logic. Third, we will determine the role of receptor dimerization
or higher order oligomerization in Wg reception by Frizzled (Fz) family GPCRs based on our discovery of
unexpected functional complementation between three of the four Drosophila Fz proteins. This analysis should
provide insight into how Wnts are transduced by the ten Fz proteins in humans.

Public health relevance
PROJECT NARRATIVE Perturbations of the intercellular signaling systems that control organ growth are a major source of human disease, associated with a wide range of developmental, physiological disorders as well as most forms of cancer. The proposed research is relevant to public health because solving how such systems normally function to direct as well as terminate growth as organs develop is essential for the development of more effective diagnostic and therapeutic treatments for this enormously broad range of afflictions. Thus, the proposed research is relevant to NIH's mission to reduce the burden to society arising from genetic and environmental disorders of fundamental aspects of human development and physiology.